Antibiotic tolerance as a stepping stone to tuberculosis drug-resistance

PROJECT SUMMARY
Antibiotic tolerance describes differential susceptibility of an isogenic bacterial population to bactericidal
antibiotics. Antibiotic tolerance contributes to two clinically relevant phenotypes: populations with increased
antibiotic tolerance are harder to eradicate and need prolonged antibiotic therapy – a hallmark of tuberculosis;
and antibiotic tolerance has been shown in some organisms to act as a stepping stone to bona fide drug-
resistance. However, there are many forms of antibiotic tolerance – ranging from non-replicating persisters to
growing phenotypic resister cells – and these most likely represent diverse physiological states, mediated by
distinct molecular mechanisms. The relative prevalence of these forms of tolerance in clinical isolates of
Mycobacterium tuberculosis – the cause of tuberculosis – is completely unknown, as is the relative contribution
of distinct types of tolerance to in vivo antibiotic susceptibility and development of antibiotic resistance. We have
developed assays that can measure the relative tolerant subpopulation caused by non-replicating persistence
and growing phenotypic resistance to the first-line anti-TB antibiotic rifampicin. Using these assays, we will
measure the relative prevalence of these distinct forms of tolerance in clinical isolates of M. tuberculosis
representing all major phylogenetic groups. By transposon insertion mutagenesis and deep-sequencing (Tnseq),
we will dissect the genetic requirements for tolerance both in vitro and in a novel murine model of tuberculosis
infection, using B6.Sp140 -/- mice that recapitulate the hallmarks of infection such as necrotic granulomata of
C3H/FeJ ‘Kramnik’ mice. We will also determine the contribution of these two forms of rifampicin tolerance to
the development of rifampicin-resistance in select clinical isolates of M. tuberculosis, and perform Tnseq to
identify genetic contributors to resistance. Together, these studies will further our understanding of the molecular
mechanisms of distinct forms of rifampicin tolerance in clinical strains of tuberculosis, and their relevance to the
development of genetic resistance.

Public health relevance
PROJECT NARRATIVE Some subpopulations of genetically identical bacteria are killed more slowly than others: this is termed antibiotic tolerance and this tolerance may contribute to the long treatment time for tuberculosis (six months) as well as the development of drug-resistance. However, there are many different forms of antibiotic tolerance with distinct molecular mechanisms and it is not known which forms are most prevalent in, and contribute most to antibiotic susceptibility in animal infection and development of drug-resistance. We will compare two different types of tolerance in clinical strains of Mycobacterium tuberculosis – the cause of tuberculosis -- and determine the genetic mechanisms by which they mediate antibiotic susceptibility and development of drug-resistance.